MULTISENSORY INTEGRATION OF VESTIBULAR AND MAGNETIC SIGNALS

DESCRIPTION (provided by applicant): Many animals can detect and use the Earth's magnetic field for orientation and navigation functions. We have recently discovered cells in the vestibular brainstem of pigeons that encode the direction and intensity of the magnetic field (MR cells); as well as being multisensory carrying vestibular linear motion signals. We have also characterized a magnetic sense neural pathway that includes regions in the brain known to be involved with spatial orientation and navigation tasks, including the vestibular nuclei, dorsal thalamus, hippocampus, and visual association cortex. The primary goal of the proposed project is to determine how multisensory convergence of vestibular and magnetic sense signals creates neural constructs that encode geopositional and heading direction information. First, we found that MR cells are spatially cosine tuned to magnetic field direction, thus these neurons encode a 3D magnetic field vector. In Aim 1, we will examine whether magnetic directional tuning is referenced to the world-fixed constant of gravity. We hypothesize that multisensory integration of vestibular and magnetic cues allows MR cell directional responses to be spatially stable and not change with head position. In Aim 2, we will determine if MR cell translational responses are fixed relative to the magnetic field direction, independent of head position. We hypothesize that MR cells provide directional heading information in magnetic field coordinates. We recently also discovered that the distinct state of gliding flight increases the sensitivity to motion in vestibuar neurons. In Aim 3, we will determine if flight increases the sensitivity of MR cells and provides for more complete reference frame transformations as outlined in Aims 1 and 2. Together, these experiments will uncover basic multisensory integration mechanisms for building neural representations of position and heading direction. These are vital functions for all animal behavior and are often compromised by vestibular trauma or disease in people. Understanding how a new magnetic sense uses vestibular motion cues through convergence to create complex information constructs will provide key insights into important brain functions and bring us closer to obtaining new treatment options disorientation maladies.

Public health relevance
PUBLIC HEALTH RELEVANCE: We have discovered brainstem neurons that combine cues from vestibular motion and magnetic sense signals to contribute to orientation in birds whose lives depend upon long distance navigation. This beautiful ability to home and migrate is demonstrated by most vertebrates and utilizes little understood abilities to detect and process information regarding the Earth's geomagnetic field. Understanding how the brain uses multisensory cues to perform computational constructs that underlie orientation function will provide specific insights into the disorientation problems people suffer with vestibular function loss.